Coding of Action by Motor & Premotor Cortical Ensembles

Abstract
The goal of this project is to understand how spatio-temporal patterns of activity across motor cortex initiate
different types of voluntary movements. Large distributed ensembles of motor cortical neurons begin
modulating their firing rates prior to voluntary movement and are thought to causally generate these
movements. However, it is still unresolved why movement is not initiated when similar modulations in single
unit motor cortical activity occur during movement planning, imagery, and visual observation of action. The
amplitude of local field potential (LFP) oscillations in the beta frequency (15-40 Hz) range is known to attenuate
prior to movement onset and is considered a mesoscopic signature of corticospinal excitability. We have
recently discovered a sequential pattern of LFP beta attenuation and single unit modulation timing in primary
motor cortex that is spatially organized prior to reaching movement onset but not during movement
preparation. Our working hypothesis is that such a propagating sequential pattern is necessary to initiate
movement. In this project, we will test and extend this hypothesis by demonstrating that such propagating
patterns generalize to movement initiation of different behaviors including 2D reaching under different
conditions, more complex 3D reach-to-grasp, and tongue protrusion and occur in premotor cortex. We will first
demonstrate that propagating sequences in beta attenuation and single unit modulation timing occur during
initiation of each of these behaviors along different portions of the somatotopic map of primary motor and
premotor cortices. Second, we will provide a causal link between these propagating patterns and movement
initiation by applying subthreshold, spatio-temporal patterns of electrical stimulation. We will demonstrate that
movement initiation is delayed when patterned stimulation travels against the natural propagating sequence
but not when it mimics the natural propagating pattern. Third, we will provide a mechanistic explanation of how
these propagating sequences lead to muscle activation that supports movement initiation using patterned
stimulus-triggered muscle activity and muscle decoding. To accomplish these aims, four high-density electrode
arrays will be chronically implanted in the either the upper limb or orofacial areas of primary motor and
premotor cortices from which 100s of single units and LFPs will be simultaneously recorded. A two-link
exoskeletal robot and a motion tracking system using a set of fourteen infrared cameras will monitor the
kinematics of the arm and hand. A strain gauge will measure tongue force and kinematics of the tongue will be
tracked with a novel 3D x-ray fluoroscopy system. Indwelling EMG electrodes will also measure activity from
arm, hand, and tongue muscles. A set of classical and novel computational methods will be employed to
characterize the spatio-temporal dynamics of motor cortical activity during movement initiation.

Public health relevance
Project Narrative Understanding how the central nervous system initiates voluntary movements of different body parts is a fundamental yet unresolved problem in systems neuroscience. The proposed project will enhance our understanding of the cortical basis of initiation which may have clinical implications for patients that suffer from problems with launching movements due to Parkinson's disease or cortical damage from stroke or injury. This work may also have relevance towards the development of more effective neural prostheses by incorporating spatio-temporal information in decoding algorithms used to control these systems.